Red-light driven targeted degradation of cancer proteins

PROJECT SUMMARY
Targeted protein degradation has emerged as a powerful method to manipulate proteins, both for mechanistic
studies and therapeutic applications. By selectively degrading a protein of interest, these modalities provide an
orthogonal way to alter protein function that is distinct from traditional pharmacological approaches, which
typically inhibit enzymatic or binding activity. Most strategies for protein degradation use bifunctional molecules,
such as proteolysis targeting chimeras (PROTACs) and molecular glues, which simultaneously engage a protein
target and the native protein degradation machinery in the cell (e.g. ubiquitin ligases) to tag the target for
destruction. The use of endogenous enzymes and pathways to facilitate targeted degradation was a
transformative concept, but reliance on these systems can also be a limitation. For example, not all cell types
express the same ubiquitin ligases, and we currently lack ligands to engage the majority of ubiquitin ligases.
Furthermore, in cancer cells, acquired resistance to PROTACs can emerge through mutations in the native
degradation machinery. Here, we propose a strategy for targeted protein degradation that obviates the
need for endogenous degradation enzymes, instead leveraging light-activated, target-localized protein
cleavage reactions.
Our proposed technology for visible light-catalyzed targeted protein degradation takes advantage of another
powerful chemical biology method: photoproximity labeling. Several groups, including our own, have developed
light-activatable catalysts that can initiate protein tagging reactions under biological conditions. When these
photocatalysts are attached to a drug molecule or antibody, they can be localized to a target protein to selectively
tag that target and other molecules in close proximity. Critically, our photocatalysts are activated by deep red
light (600-800 nm), which is tissue penetrant and non-toxic. In this project, instead of using photoproximity
labeling to tag proteins, we will use this technology to catalyze peptide bond cleavage reactions. Our
photocatalysts will be conjugated to highly selective ligands targeting key cancer proteins, and these conjugates
will be used to initiate light-catalyzed protein degradation reactions. In Aim 1 of this study, we will optimize the
catalytic system and cleavage reactions for high efficiency. In Aim 2, we will demonstrate that this system is
compatible with the targeted degradation of a cell surface protein, the immune checkpoint receptor, PD-1. In Aim
3, we will optimize catalysts for the degradation of an intracellular protein, the oncogenic phosphatase SHP2.
Successful development of our photocatalytic degradation technology will enable a new strategy to
degrade proteins with high spatial and temporal precision. This technique could be used to ablate cancer
proteins in live cells or living organisms, to investigate the functions of those proteins or for therapeutic purposes.

Public health relevance
PROJECT NARRATIVE The ability to control a protein’s fate or function in a living animal using visible light as a stimulus could be a powerful way to interrogate the disease relevance of that protein and treat diseases driven by that protein’s activity, all with high spatial and temporal resolution. In this project, we will develop a technology to selectively degrade cancer-relevant proteins using tissue-penetrant, non-toxic light (600-800 nm). Our method will enable new mechanistic studies into cancer proteins and lay the foundation for the development of light-activated cancer therapies.